Deciphering the cis-regulatory logic of circadian reprogramming in a mouse model of Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s Disease (AD), the most common origin of dementia, is frequently accompanied by circadian rhythm
disruption. It is not clear how circadian function relates to neurodegeneration, but deletion of the core circadian
transcription factor (TF) BMAL1 in astrocytes causes both an AD-like cellular phenotype and increased neuron
loss after oxidative stress. Within astrocytes of a mouse model of AD, we have observed a phenomenon known
as circadian reprogramming, in which some genes lose circadian expression while other genes gain circadian
expression. The goal of this proposal is to determine how circadian reprogramming is regulated in astrocytes of
our AD mouse model. I hypothesize that within AD-model astrocytes, BMAL1 interacts with disease-specific TFs
to bind to new genomic locations and cause new genes to become rhythmic. To test this hypothesis, I will 1)
determine whether BMAL1 changes in astrocytes of our AD mouse model to bind to reprogrammed genes (Aim
1), and 2) identify TF motif combinations sufficient to produce circadian gene expression and reprogramming in
astrocytes of our AD mouse model (Aim 2). To characterize BMAL1 binding in Aim 1, I have preliminary data
that FLEXCCs, a technology to record TF binding on a cell type specific level, can be used to record BMAL1
binding. For this project, I will use FLEXCCs to record BMAL1 binding in astrocytes of both wildtype mice and in
our AD mouse model. In Aim 2, I will identify TF motif combinations that drive circadian expression in our AD
mouse model using a Massively Parallel Reporter Assay (MPRA) and capture astrocytic transcripts with
translating ribosome affinity purification and RNA-sequencing (TRAP-seq). This proposal will begin to determine how
the cellular environment of AD-like astrocytes generates circadian reprogramming. By establishing a mechanism
of circadian reprogramming in astrocytes in a mouse model of AD, I will help elucidate how circadian disruption
progresses in AD and uncover new pathways to potentially alter disease course.

Public health relevance
PROJECT NARRATIVE Circadian rhythm disruption is a common feature of Alzheimer’s disease and one of the major causes of patient institutionalization. A common mouse model of the disease has been found to exhibit a phenomenon known as circadian reprogramming, in which a subset of genes loses circadian expression while another subset gains circadian expression. This project will determine how transcription factors coordinate circadian reprogramming and generate novel circadian expression within the context of neurodegeneration, which will provide novel insight into how Alzheimer’s disease progresses and potentially uncover new pathways to alter disease course.